The miRNA-mediated Translational De-suppression in Hypoxic Endothelium

DESCRIPTION (provided by applicant): MicroRNAs (miRNAs) are non-coding small RNAs that regulate gene expression at the post- transcriptional level. Ranging from 18 to 24 nt (22 nt in general), miRNAs regulate gene expression by suppressing protein translation of target mRNAs or enhancing their degradation. miRNAs targeting mRNAs depends on the association of the miRNA/mRNA complex with Argonaute (Ago) endonuclease to form the miRNA-induced silencing complex (miRISC). We used sequencing by synthesis (SBS) deep sequencing to study the miRNAs in cultured vascular endothelial cells (ECs) exposed to hypoxia and bioinformatics approaches to analyze the hypoxia-responsive miRNAs at the genome-wide scale. Among miRNAs with greatly changed expression, Let-7s and miR-103/107 target Ago1. This result suggests that a miRNA- mediated translational de-suppression mechanism may occur in ECs under hypoxia. With these data acquired from high-throughput screening and in silico approaches, two specific aims are proposed to test the hypothesis that under hypoxia, the increased Let-7s and miR-103/107 down-regulate Ago1. Such a suppression of Ago1 decreases miRISC-mediated miRNA targeting and hence up-regulates targeted mRNAs, which encode highly translated proteins in ECs responding to hypoxia. Specific Aim 1 will study the Ago1- regulated miRNA/mRNA targeting in ECs responding to hypoxia. We will use Ago1 cross-linking immunoprecipitation sequencing (CLIP-seq) to profile the miRISC-associated miRNAs and their mRNA targets in ECs under normoxia and hypoxia. Specific Aim 2 will decipher the functional consequences of the miRNA- mediated translational de-suppression in cultured ECs and mouse hindlimb. Specifically, we will manipulate the expression of Let-7s and miR-103/107 in vitro and in vivo. The miRISC-mediated miRNA/mRNA targeting and mRNA-encoded proteins under normoxia and hypoxia will be examined. The elucidated mechanism will reveal mechanistic insights underlying the miRNA-regulated gene expression in ECs in response to hypoxia.

Public health relevance
PUBLIC HEALTH RELEVANCE: MicroRNAs are non-coding small RNA that regulates gene expression. This project is to study the role of microRNA in regulating gene expression in vascular cells under low oxygen tension, namely, hypoxia. We will use state-of-art sequencing method to obtain microRNA sequences that are increased in cells under hypoxia. As a result, some of the proteins are highly expressed. Results from this research may have translational potential for hypoxia-related diseases such as myocardial infarction and cancer biology. MicroRNAs are non-coding small RNA that regulates gene expression. This project is to study the role of microRNA in regulating gene expression in vascular cells under low oxygen tension, namely, hypoxia. We will use state-of-art sequencing method to obtain microRNA sequences that are increased in cells under hypoxia. As a result, some of the proteins are highly expressed. Results from this research may have translational potential for hypoxia-related diseases such as myocardial infarction and cancer biology. __SpecificAimsTextDelimiter__ SPECIFIC AIMS MicroRNAs (miRNAs) are non-coding small RNAs that regulate gene expression at the post- transcriptional level. Ranging from 18 to 24 nt (22 nt in general), miRNAs regulate gene expression by suppressing protein translation of target mRNAs or enhancing their degradation. To date, 721 human miRNAs have been identified, and these miRNA are suggested to regulate the expression of up to 70% of all transcripts in various tissues (http://www.mirbase.org). miRNAs targeting mRNAs depends on the association of the miRNA/mRNA complex with Argonaute (Ago) proteins to form miRNA-induced silencing complex (miRISC). Among the Ago family proteins present in human cells, Ago1 is proposed to be involved in the translational suppression of target mRNAs (Wang et al., 2009a). Constituting the inner layer of blood vessels, vascular endothelial cells (ECs) play key roles in maintaining cardiovascular homeostasis. Physiological or pathological stimuli such as hypoxia/ischemia, significantly affect endothelial functions, including proliferation, apoptosis, migration, and angiogenesis. These functions are controlled by EC gene expression that is regulated at both transcriptional and post-transcriptional levels. Under hypoxia, most protein translation is suppressed. However, a set of hypoxia-induced proteins are highly translated (Arsham et al., 2003; Semenza and Wang, 1992). The mechanisms underlying this translational preference remain elusive. Analyses of miRNA expressed in arterial walls and cultured ECs demonstrated that nearly 30 miRNAs are highly expressed in ECs. Emerging evidence indicates that physiological or pathophysiological cues regulate the expression of these miRNAs, which in turn affects EC functions (see Suárez and Sessa; 2009; Kuehbacher et al., 2008 for review). With the use of miRNA microarray, recent studies showed that the level of several miRNAs is modulated by hypoxia in several cell lines (Kulshreshtha et al. 2007; Hua et al. 2006), and thus these miRNAs are termed hypoxia-responsive miRNAs (HRMs) (Kulshreshtha et al., 2008). However, the expression of HRMs, their mRNA targets, and the consequent functional changes in ECs are largely unknown. Using sequencing by synthesis (SBS) deep sequencing, we have begun to study miRNAs in cultured human ECs exposed to hypoxia and use bioinformatics approaches to analyze the HRM expression profile (see Fig. 1-3 in Preliminary Studies). Results from these experiments have identified miRNA expression profile at the genome-wide scale. Among the miRNAs with greatly changed expression, Let-7a-i (Let-7s) and miR- 103/107, two highly conserved miRNA families across species, are predicted by bioinformatics to be induced by hypoxia-inducible factors 1α (HIF1α) and to target Ago1 for silencing. Indeed, Western blotting confirmed the down-regulation of Ago1, but not Ago2, in ECs under hypoxia. These results suggest that several miRNAs, via down-regulating Ago1, may mediate translational de-suppression in ECs. With these data acquired from high-throughput screening and bioinformatics approaches, two specific aims are proposed to test the hypothesis that under hypoxia, the increased Let-7s and miR-103/107 down-regulate Ago1. Such a suppression of Ago1 decreases the miRISC-mediated silencing of miRNA targets, hence up-regulating their targeted mRNAs, which encode highly translated proteins in ECs responding to hypoxia. Specific Aim 1: To study the Ago1-regulated miRNA/mRNA targeting in ECs responding to hypoxia. We will use Ago1 cross-linking immunoprecipitation sequencing (CLIP-seq) to profile the miRISC-associated miRNAs and their mRNA targets in ECs under normoxia and hypoxia. Specific Aim 2: To decipher the functional consequences of the miRNA-mediated translational de- suppression in cultured ECs and mouse hindlimb. Specifically, we will manipulate the expression of Let-7s and miR-103/107 in vitro and in vivo. The miRISC-mediated miRNA/mRNA targeting and the mRNA-encoded proteins under normoxia and hypoxia will be examined. Summary of hypothesis and Specific Aims. The arrows in red indicate the up- or down-regulation of the various molecules in ECs under normoxia or hypoxia.